MALT1 as a rational therapeutic target in African American ancestry patients with DLBCL

ABSTRACT
Diffuse large B-cell lymphoma (DLBCL) is the most frequent B-cell non-Hodgkin lymphoma (B-NHL). The
treatment of these diseases remains challenging, with many patients ultimately dying. Despite the clinical
success of recent advanced immunotherapies against different tumor types, DLBCLs are largely refractory to
these new therapies. The immune resistance mechanisms of these diseases are unclear. The heterogeneity
of DLBCLs suggests that their treatment can benefit from precision-medicine approaches. Mutations in the
TLR mediator MYD88 and B-cell receptor (BCR) signaling molecules, including CD79B, define the MCD-
DLBCL subtype, which displays the greatest aggressiveness and refractoriness to therapies. MYD88 and
BCR pro-lymphoma signals are integrated by a downstream molecular complex, whose major functional
subunit is MALT1. Targeting MALT1 thus represents an attractive option to specifically interrupt the driver
pro-lymphoma signals of these aggressive diseases and block their growth. Our collaborators developed the
first selective MALT1 inhibitor (MALT1i) and contributed to the generation of the first MALT1i ever tested in
patients (NCT03900598; NCT04876092; NCT04657224). Notably, MALT1 is also active in cells that dampen
anti-tumor immunity, specifically immunosuppressive regulatory T cells (Tregs) and exhausted T cells (Tex),
which are incapable to react and kill tumor cells. Thanks to our unique access to newly developed MCD-
DLBCL mouse models, which harbor an intact immune system, we can now for the first time reliably examine
the direct anti-tumor and immune-mediated effects of MALT1is, and their potential for combination with
immunotherapy. Our preliminary studies in these models show that MALT1is decrease MCD-DLBCL cells as
well as lymphoma-infiltrating Tregs and Tex. Moreover, we find that MALT1is increase MCD-DLBCL antigen
presentation and co-stimulatory potential as well as T-cell activation and tumoricidal function, which may
overall promote anti-lymphoma T-cell responses. Thus, we hypothesize that pharmacologic MALT1 inhibition
in the setting of MCD-DLBCLs will have dual positive anti-tumor effects: (1) limiting tumor proliferation, by
interrupting the MYD88 and BCR pro-lymphoma signals and (2) potentiating anti-lymphoma immunity, by
counteracting immunosuppressive and dysfunctional T cells and increasing lymphoma cell immunogenicity.
Based on this hypothesis, our objective is to establish optimal combinations of MALT1is with immunotherapy
able to eradicate otherwise immune evasive aggressive lymphomas. Toward this goal, we will test clinically
relevant MALT1is alone and in combination with immunotherapy against MCD-DLBCLs in syngeneic mouse
models with normal vs. defective immune system (i.e. lacking specific T-cell subsets/function) to discover the
mechanisms by which MALT1 inhibition promotes anti-lymphoma immunity. Moreover, we will perform the
first validation that MALT1is can activate T-cell responses in patients enrolled in NCT03900598.

Public health relevance
PROJECT NARRATIVE This project will pioneer an innovative approach to treat highly aggressive and therapy refractory B-cell lymphomas (MCD-DLBCLs) using MALT1 targeted therapy, which interrupts key lymphomagenic pathways and at the same time has the potential to disengage anti-lymphoma T-cell responses. Using newly developed MCD-DLBCL models and fully immunocompetent syngeneic host mice in comparison with host mice lacking specific arms of the immune system, we will elucidate the contribution of T-cell responses to the anti- lymphoma activity of MALT1 inhibition. Building on this, we will establish optimal regimens of MALT1 inhibition to enhance the efficacy of immunotherapy against MCD-DLBCLs in preclinical settings and study similar effects of MALT1 inhibition in lymphoma patients enrolled in the first in human trial with a MALT1 inhibitor, thus providing the proof-of-principle to investigate its combination with immunotherapy in the clinic.